Elucidating clinical heterogeneity in early-onset AD via genomics, transcriptomics, and neuroimaging

Project Summary/Abstract
Early-onset Alzheimer's disease (EOAD) is defined by an onset before age 65 and is characterized by the
same neuropathology of late-onset Alzheimer's disease (LOAD). There is a common misconception that EOAD
occurs primarily as an autosomal dominant disease, yet pathogenic variants in APP, PSEN1, and PSEN2
account for merely 5% of all EOAD cases. Only half or fewer EOAD patients carry the strong AD risk factor,
APOE*E4. Nevertheless, family studies indicate that EOAD has a stronger heritable component than LOAD,
suggesting a large portion of genetic risk remains unknown. Adding further complexity, unlike the typical
episodic memory impairment of LOAD, EOAD often presents with “atypical” clinical symptoms (i.e., executive,
visuospatial, or language dysfunction) due to neurodegeneration of specific associated brain networks.
Although LOAD and EOAD are defined by the same neuropathology, the fact that different underlying brain
networks are affected suggests that EOAD results from a distinct underlying molecular etiology. The long-term
goal of this work is to elucidate the genetic drivers of clinical heterogeneity in EOAD in order to develop
predictive measures of individualized disease risk. In the present study, 900 EOAD, LOAD, and healthy age-
matched controls will be studied through whole genome sequencing for novel genetic variation contributing to
EOAD disease risk. Single-cell droplet-based RNA-sequencing will also be performed on a subset of patients
to identify signatures of peripheral gene expression that distinguish EOAD patients. Finally, changes in gene
expression will be related to patterns of brain atrophy to identify the group of genes contributing to selective
neuroanatomical vulnerability in clinical subgroups of EOAD patients. The underlying hypothesis of this study is
that there are different networks of genes linked by common biological pathways that drive selective
vulnerability to each of the three brain networks that are vulnerable in different cases of EOAD. The specific
aims of this project are: (1) Distinguish between EOAD genetic risk and LOAD genetic risk; (2) Identify gene
expression differences between EOAD and LOAD; (3) Evaluate whether gene expression patterns predict
EOAD atrophy patterns. Identifying underlying genetic risk contributing to EOAD clinical heterogeneity will
inform our understanding of disease biology. In addition, predicting in advance which network is most
vulnerable may enable us to identify the cognitive functions that should be monitored most closely during
preclinical stages of disease in a patient-specific manner. The proposed cross-sectional study will lay the
foundation for future work assessing the clinical value of using genomic, transcriptomic, and imaging profiles in
combination to predict disease presentation and clinical progression in longitudinal cohorts of EOAD patients.
This work will contribute to our biological understanding of variability in AD and may inform future efforts to
develop personalized genomic medicine for EOAD prognostication and tracking during clinical intervention
trials.

Public health relevance
Project Narrative The goal of this study is to utilize genomic, gene expression, and neuroimaging data to elucidate molecular contributions to clinical variability in early-onset Alzheimer's disease. This research is relevant to public health because we will identify novel genetic variation and develop biomarkers that provide information about disease risk. In addition, the results of the proposed research will enhance our understanding of the biological mechanisms underlying early-onset Alzheimer's disease and may ultimately lead to identification of new targets for therapeutic intervention.